CALCIUM IN THE PREVENTION OF NEOPLASTIC POLYPS

This study is designed to test the efficacy of calcium supplementation in preventing the recurrence of adenomatous polyps of the large bowel. This study is a multicenter randomized, double-blind, placebo-controlled clinical trial.